The Kansas Institute for Precision Medicine: IsoPlexis IsoSpark

ABSTRACT
The long-term goal of the Kansas Institute for Precision Medicine (KIPM) is to develop a multi-disciplinary
research environment focused on the theme of precision medicine that will advance healthcare through
innovative scientific discoveries. This will be accomplished through this Phase I COBRE program, which will
develop an innovative training paradigm of physician/scientists that is fortified by an experienced set of directors
and mentors with experiences in biomedical research, state-of-the-art research cores, and an organizational
structure all built around the precision medicine theme. This KIPM COBRE will be led by Andrew K. Godwin,
PhD (Director), Steven A. Soper, PhD (Associate Director), and Alan S.L. Yu, MB, B. Chir (Director of Mentoring
and Career Development) and will train promising young scientists under the auspices of precision medicine.
The Administrative Core will be responsible for the overall management of the administrative, fiscal, and scientific
aspects of KIPM. This Core will play an important leadership role in the COBRE program by setting the overall
scientific direction of KIPM’s activities, coordinating, and integrating all of the KIPM’s functions, establishing and
delineating areas of research emphasis, and promoting internal and external collaborative interactions. Dr.
Godwin will have primary administrative oversight of the COBRE through the Administrative Core, but all KIMP
activities will be managed and evaluated jointly by the three principal investigators. The specific aims of the
Administrative Core will be to: 1) provide administrative leadership and coordinate the research effort by
providing the appropriate financial accounting, clerical and other program management support; 2) design and
implement a mentoring and career development plan for junior faculty members; 3) convene an internal and an
external advisory committee to evaluate the KIPM COBRE; 4) administer and evaluate a research pilot project
program; and 5) develop training and infrastructure for patient and community engagement and implementation
of precision medicine in primary care practices. These activities will be assisted by Ms. Jessica Leib, who will
meet regularly with each of the COBRE faculty to review their available funding and track expenditures.
Additionally, she will help administer the fiscal accounting for all the proposed pilot projects, coordinate meetings,
travel and activities for the external faculty mentors, the internal and external advisory board members, patient
advocates, and members of the Patient and Community Engagement (PACE) Council. Overall, the proposed
KIPM COBRE Administrative Core will promote and strengthen interactions between the COBRE and the parent
institution by interfacing its activities with other programs, centers, and institutes at KUMC, and by integrating
the biomedical research cores with existing institutional shared resource centers.

Public health relevance
PROJECT NARRATIVE It is becoming increasingly evident that functional proteomics is needed to characterize the heterogenous cell populations involved in cutting-edge cell, immune, and cancer therapies. IsoPlexis technology is the only system that provides researchers with the ability to address these needs using highly multiplexed cytokine and phosphoprotein data at a single-cell level. Installing an IsoSpark will provide the KUMC campus with the ability to access the proteome for deep characterization capabilities.